AGT001 for Scleroderma Kidney

SUMMARY
Systemic sclerosis is an autoimmune disease that affects predominately females, and it is characterized by
severe fibrosis of the skin and internal organs. Scleroderma kidney (SK) is a rare but severe complication
characterized by accelerated hypertension and progressive kidney injury. Pathophysiology involves intimal
thickening and proliferation of intralobular and arcuate kidney arteries leading to renal hypoperfusion, ischemia
and therefore a marked increase in renin production. Consistent with this pathophysiology, Angiotensin
converting enzyme (ACE) inhibitors sometimes result in dramatic improvements and, since they were introduced
in the 80s, remain the primary form of therapy. However, a substantial proportion of treated patients, 20-50%,
still progress to end stage kidney disease and 5-year survival is only 50-70%. Angiotensin II can drive organ
fibrosis. In addition, recent work has shown concentric hypertrophy of renal arterioles in rodents and patients
treated long term with RAS blockers as a result of increased numbers of renin producing cells in renal arterioles.
For all these reasons there is an urgent need to identify new treatments for SK other than the widely used RAS
blockers. The renin angiotensin system (RAS), however, is still an attractive and safe pathway to target new
therapies for SK. We will use a renin transgenic mouse (RenTg) that replicates many of the features of the SK
including intima thickening and proliferation of the renal intralobular arteries with the classic “onion skinning”
appearance to determine if increasing the degradation of Ang II using our bioengineered soluble angiotensin-
converting-enzyme 2 (AGT001) can provide a primary form of therapy for the SK. ACE2 is a tissue peptidase
abundant in the kidneys that catabolizes Ang II. To be able to deliver ACE2 to the kidney, we bioengineered
AGT001, a shorter form of ACE2, that can pass the glomerular filtration barrier. By fusing it with the Albumin
binding domain (ABD) we were able to extend the duration of action from hours to days. We anticipate that the
administration of AGT001 will ensure the dissipation of not only circulating Ang II but also Ang II within the kidney,
thereby decreasing fibrosis within the kidney. This proposal will determine the dosing of AGT001 for efficacy
when given RenTg mice to improve kidney pathology, proteinuria and hypertension in this mouse SK model.
Moreover, safety and PK studies will be performed. The proposed work will lay the foundation for a novel
treatment of SK based on amplification of systemic and renal ACE2 activity to lower Ang II as a strategy to
mitigate long-term deleterious effects of this devastating disease. Successful completion of the proposed studies
will support a Phase II application and eventually advancement of this therapy to IND-enabling studies. Our
ultimate goal is to submit this novel SK therapy to the FDA for first-in-human clinical safety trials with a
designation for an orphan disease.

Public health relevance
NARRATIVE Scleroderma kidney is a rare but severe complication of systemic sclerosis characterized by accelerated hypertension, proteinuria, and progressive kidney injury and there is an urgent need to identify novel treatments to improve outcomes in patients with scleroderma kidney. In this proposal, in a mouse model of scleroderma kidney, different dosing and schedules of administration of a novel soluble ACE2 protein (AGT001) will be used to examine its effectiveness in maintaining renal function and improving kidney histopathology. Success of those studies will provide further validation of this therapeutic approach and lay a strong foundation for moving AGT001 to clinical studies.